Evaluation of CMS Transitional Care and Chronic Care Management Services: Bridging the Gap and Maximizing Potential

PROJECT SUMMARY
With increasing life expectancy of US population, healthcare systems are faced with the challenge of improving
the health of older adults while containing healthcare costs. The health outcomes and healthcare costs of older
adults are significantly influenced by multimorbidity, frailty, and poor social determinants of health. There is an
increasing effort to shift disease-based care toward patient-centered care that addresses patients' medical and
psychosocial needs and enhances care coordination. To this end, the Centers for Medicare & Medicaid Services
introduced Transitional Care Management (TCM) in 2013 and Chronic Care Management (CCM) services in
2015. Despite the premise of these services, they are not delivered to patients who need these services most.
The objective of this proposed research is to narrow this practice gap by evaluating the effectiveness of TCM
and CCM and develop strategies to increase adoption of these services. The central hypothesis of this project
is that TCM and CCM services are more effective in increasing days at home (home time), survival, and reducing
total Medicare costs than usual care in older adults, particularly those with frailty, dementia, and poor social
determinants of health; the uptake of these services is affected by patient-level, caregiver-level, and practice-
level factors. A team of experts in geriatrics, health services research, causal inference, health economics, and
qualitative research will accomplish the following specific aims: 1) determine the effectiveness of TCM and CCM
on home time, survival, and healthcare costs by emulating target trials of TCM and CCM in Medicare fee-for-
service and Medicare Advantage beneficiaries; 2) develop and validate prediction models to identify patients
who are more likely to benefit from TCM and CCM; and 3) identify patient-level, caregiver-level, and practice-
level facilitators and barriers in adopting TCM and CCM by conducting a large, multiregional qualitative study of
30 practices of high-volume, low-volume, and former use of TCM and CCM. The innovation of this research
includes its target trial emulation approach to evaluate the effectiveness of TCM and CCM compared with usual
care; use of patient-centered outcome home time; inclusion of contemporary Medicare fee-for-service and
Medicare Advantage beneficiaries; and mixed methods approach of conducting a multi-regional qualitative study
informed by a quantitative analysis of the national Medicare data. This research is significant because the results
can inform development of strategies to increase clinical adoption of TCM and CCM services in beneficiaries
who are most likely to benefit from each service. Ultimately, appropriate use of TCM and CCM will enhance
patient-centered coordinated care and reduce healthcare costs in aging populations.

Public health relevance
PROJECT NARRATIVE The proposed research aims to evaluate the effectiveness of the Centers for Medicare & Medicaid Services Transitional Care Management and Chronic Care Management and develop strategies to increase adoption of these services. This research is relevant to public health because the research findings will enable a targeted delivery of resource intensive care management services to Medicare beneficiaries who are most likely to benefit from these services. Thus, it accomplishes the National Institute on Aging's missions and initiatives to improve the health status of older adults and tame rising Medicare expenditure.